Impact of Dual Enrollment in the VA and Medicare Advantage on Care and Outcomes for Veterans

Background: The share of Medicare beneficiaries enrolled in private health plans through Medicare Advantage
(MA) has increased rapidly over the past 2 decades with half of Medicare beneficiaries enrolled in MA. Our
preliminary data suggest 1.8 million Veterans (nearly 20% of all VA enrollees) were enrolled in an MA plan in
fiscal year 2020. The vast majority of prior studies focused on Veterans dually enrolled in VA and the
traditional Medicare (TM) program, but fundamental differences in program design preclude prior estimates of
dual use from being applicable to Veterans in MA. There are major gaps in knowledge about the recent growth
of dual VA-MA enrollment, whether certain subpopulations of Veterans were more likely to enroll in MA, and
how VA-MA enrollment impacts use and reliance of VA services (as a proportion of total care) and health
outcomes.
Significance: The VA must address the challenges of financing and caring for dually enrolled Veterans,
especially as enrollment in MA is projected to cover a majority of Medicare beneficiaries over the next several
years. Recent growth in MA enrollment has been substantially higher among racial/ethnic minority and low-
income populations, but whether these trends extend to Veterans and the implications of MA enrollment on
disparities in the VA population have been unexplored.
Innovation & Impact: This proposal will be among the first to examine reliance for Veterans in MA, it will
perform a novel linkage of VA, Medicare Advantage encounter, and detailed contract-level information on MA
network breadth, benefit design, and provider integration, and it will extend prior research comparing outcomes
in TM and MA that relied on cross-sectional approaches by using quasi-experimental methods to account for
favorable selection into MA.
Specific Aims: Aim 1 will characterize trends in dual VA-MA enrollment among Medicare-eligible veterans and
VA spending, utilization, and reliance of dually enrolled veterans from 2016-2023 and examine the role of VA
facility characteristics. Aim 2 will compare differences in VA utilization of different types of services and health
outcomes between Veterans who enroll in MA versus traditional Medicare. Aim 3 will examine in more depth
the consequences of MA enrollment by estimating VA reliance by Veteran factors such as clinical complexity
and social risk factors and MA plan factors for VA-MA enrollees.
Methodology: This quantitative project will use national VA-Medicare linked datasets on enrollment, utilization,
costs, and payments to measure trends in dual enrollment, VA utilization, spending and reliance for VA-MA
patients compared to VA-TM patients over a seven-year period. We will use quasi-experimental methods to
address the favorable selection of enrollees into MA versus TM and to compare outcomes for these two dually
enrolled populations before and after Medicare enrollment.
Next Steps/Implementation: Data from this proposed study will be used to update the VA Enrollee
Projection Model by the VA Chief Strategy Office for strategic planning and budgeting of VA health
care. These data will also be used by the VA Office of Integrated Veteran Care to implement the
Maintaining Internal Systems and Strengthening Integrated Outside Networks Act to allocate resources
and also develop new legislation to fund VA purchased care. These national program offices need better
data on dual VA-MA enrolled Veterans for programs to support older and disabled Veterans and ensure
adequate federal funding to support Veterans’ health care needs.

Public health relevance
The rapid growth of Medicare Advantage (MA) enrollment poses new challenges to care coordination and care planning for dual VA-MA enrolled Veterans. We propose to examine the conquences of MA enrollment on reliance and use of VA services, spending, and health outcomes for Veterans nationally between 2016 and 2023. We plan to use VA-Medicare linked datasets on utilization, costs, and payments to measure overall trends in dual enrollment, VA spending, utilization, and reliance; to measure differences in utilization of different types of services and health outcomes for Veterans enrolled in MA versus traditional Medicare; and to compare VA reliance by key Veteran and MA plan factors. These data are urgently needed to support the work of the VA Chief Strategy Office, the VA Office of Integrated Veteran Care, and VA medical centers to fund and coordinate Veterans’ care.